Machine learning for identifying antigen-antibody interactions from massive sequencing data

Project Summary
We aim to leverage machine learning to predict antigen-antibody interactions from massive sequencing data, for
elucidating the roles of humoral immunity in various biological contexts, for discovery of antibodies of therapeutic
values, and for development of diagnostic tools for immune-related diseases. Existing experimental methods for
profiling antibody-antigen interactions are costly, time-consuming, and low-to-mid throughput, necessitating the
need for AI-driven predictions. However, existing bioinformatics tools mainly optimize antibodies given antigen
targets, whereas de novo detection of antibody-antigen interactions requires a different approach.
Luckily, recent scientific developments have provided opportunities to solve this problem of fast, cheap and
accurate detection of antigen-antibody interactions: (1) High-throughput sequencing technologies, like Libra-Seq,
Beam-B and TRAPnSeq, have provided abundant antigen-antibody pairing data for training deep learning
models. (2) The emergence of protein structure prediction models like AlphaFold3, RoseTTAFold and ESMFold
have provided enabling weapons. (3) The introduction of multiplexed scRNA-seq/scBCR-seq data has provided
another layer of complementary evidence to enhance the prediction of antigen-antibody interactions.
We build on these new technologies/data, and our prior achievements and unique expertise in the relevant fields.
We plan to develop and validate deep learning models to accurately identify antibody-antigen interactions and
the binding epitopes on antigens from massive sequencing data (Aim 1). A complementary approach to integrate
the transcriptomics of B cells with the BCR (B cell receptor, antibody) sequences is also taken to distill the gene
expression information for enhancing the accuracy of antibody-antigen predictions (Aim 2). We seek to identify
PD-L1-based PD-1 agonistic antibodies for autoimmune diseases, using the tools that we previously developed
and those that are to be developed in this grant (Aim 3). This case study of PD-L1 antibodies has its own
significance and innovation, but will also help validate and tune the tools to be developed in Aim 1 & 2.
The multidisciplinary team includes experts in bioinformatics, computer science, and immunology, each
responsible for different aspects of the research project. In particular, our prior research demonstrates expertise
in deep learning of protein structures, development of novel therapeutic antibodies, and methodological
development for single cell sequencing data analysis, which are essential for the success of this proposal.
The impact of the research includes providing powerful tools for understanding the roles of B cells and BCRs in
immune-related diseases, reducing the time and cost of identifying therapeutic antibodies (e.g. PD-L1-based
PD-1 agonistic antibodies), aiding in vaccine development, and the derivation of BCR-based diagnostic and
prognostic biomarkers for various diseases involving humoral immunity. We will disseminate our tools through
workshops and webportals. Overall, the project addresses major unsolved problems in the field of B cell
informatics that recently become solvable due to the advance of science and our latest works in this field.

Public health relevance
Project Narrative The project aims to utilize machine learning to understand and predict antigen-antibody interactions, potentially leading to diagnostic and therapeutic advancements in immune-related diseases. By developing deep learning models for the binding of antigens and antibodies, and leveraging multiplexed scRNA-seq/BCR-seq data, the team aims to overcome the limitations of current experimental methods and bridge the gap between bioinformatics and immunology. Their multidisciplinary approaches and expertise in data science and immunology will significantly impact the development of diagnostic tools, therapeutic antibodies, and vaccine strategies for diseases involving humoral immune responses.